Mechanisms and Regulation of Cell Division in Bacteria

PROJECT SUMMARY
A
my
scale
splitting
middle)
and
use
studies,
cytoskeletal
protein
variants
coli
conformation
conformational
genetics,
protein
result,
interact
phase
to
interactions,
subtilis
cell
oligomeric
the
and
these
provide
city-cell's
cell is like a city, with an organized yet dynamic infrastructure grouped into specialties. For nearly 30 years,
lab has investigated how the simplest cells — bacteria — organize themselves at the cellular and molecular
to divide and proliferate. We mainly f ocus on how bacteria such as E. coli achieve the daunting task of
themselves in two at the right time (once their genetic material is duplicated) and place (exactly in the
every 20 minutes. The keys to this s uccess are ancient versions of protein polymers of actin (FtsA)
tubulin (FtsZ), which our lab visualized for the first time in living bacteria over 25 years ago. Today, we
state of the art super-resolution imaging along with molecular genetics, protein biochemistry, interaction
and in vitro reconstitution, to gain more detailed insights into the structure and regulation of these
polymers and their associated proteins, which comprise the dynamic membrane-associated
nanomachine (the divisome) that divides bacterial cells. Our early characterization of hypermorphic
of FtsA and FtsZ paved the way for a model, now strongly supported by numerous studies, that the E.
divisome initially assembles in an inactive form, then becomes activated mainly by changes in protein
and oligomeric state. Nonetheless, many f t he mechanisms that trigger and respond to these
and oligomeric changes remain unclear. In the last grant period, we used our expertise in
cellular imaging, and in vivo crosslinking to discover novel and physiologically significant protein-
interactions among essential divisome proteins and develop new tools to study their function. As a
we overturned several long-established assumptions about how FtsA, FtsZ and t heir binding partners
and function. In addition, in collaborative studies we explored the ability of FtsZ to form l iquid-liquid
condensates, which have the potential to transform how we think about the divisome and its response
stress. In this proposal, we plan to continue our investigation of the cellular implications of molecular-scale
using the E. coli divisome as the model but also expanding our studies of the divisome of Bacillus
, the predominant Gram-positive model. We will address the most pressing questions about bacterial
division, which include how protein-protein interactions and switches in protein conformation and
tate sequentially trigger setup and assembly of the divisome; (2) how a third stage, synthesis of
division eptum, is licensed and activated; (3) how the divisome interfaces with chromosome segregation
cell wall synthesis. As we have done extensively in the past and in the last grant period, we will leverage
approaches with collaborations. Our ongoing investigation of how the simplest ells divide continues to
greater understanding of how an entire cell functions and reproduces. Having an accurate map of that
dynamic infrastructure will allow predictions to be made about how it works, and how to disrupt it.
o
s
s
c

Public health relevance
PROJECT NARRATIVE Infectious bacteria are becoming more widespread and resistant to most existing antibiotics. Therefore, the study of how bacterial cells regulate their growth and division, a process essential for bacteria to colonize their host and proliferate, is relevant to public health because regulators of the cell wall synthesis machinery represent novel targets for new therapeutics.